Lung Screening: Efficacy versus Effectiveness

In 2011, the National Lung Screening Trial (NLST) reported a 20% reduction in lung cancer
mortality for participants screened with low-dose CT (LDCT) as opposed to chest X-ray. Based
largely on these findings, LDCT lung screening is now a covered service for 8.7 million high-risk
current and former smokers in the United States. For high-risk individuals younger than 65,
insurance coverage is mandated under the Affordable Care Act; for those 65 and over
screening is covered by Medicare. Medicare covers lung screening only if patients are enrolled
in a Centers for Medicare and Medicaid Services-approved lung screening registry. The
American College of Radiology Lung Cancer Screening Registry (ACR-LCSR) is the only
registry currently approved by CMS. Although most medical societies have endorsed CT for
lung cancer screening, the American Academy of Family Physicians concluded that the
evidence was insufficient to recommend either for or against lung screening, as the results of
the NLST had not been replicated in a community setting. Concerns regarding the
dissemination of lung screening focus on 1) the high rate of false positive (FP) screens, for
which participants receive a positive screening result and require additional testing, but do not
have lung cancer, 2) the relatively high rate of potentially clinically important significant
incidental findings (SIFs) detected at lung screening that are unrelated to lung cancer, and 3)
potential harms from the diagnostic evaluation of these FP and SIF abnormalities. It is unclear
whether the rate of FPs and SIFs seen in the NLST, will be replicated in community practice, as
opposed to a clinical trial setting. Higher rates of FPs and SIFs in the community or inefficient
diagnostic evaluation may result in delayed cancer diagnosis, excessive testing, iatrogenic
complications due to unnecessary testing, or decreased cost-effectiveness of lung screening in
the community, as opposed to the NLST. For the proposed research, we plan to: 1) compare
the rate and type of abnormalities suspicious for lung cancer and the rate and type of SIFs in
the ACR-LCSR community registry data as opposed to the NLST, 2) compare the diagnostic
pathways used to assess these abnormalities in the community as opposed to the NLST, and 3)
use a decision-tree cost-effectiveness analysis to compare community lung screening with
NLST cost-effectiveness assumptions with respect to rates of lung and SIF abnormalities and
diagnostic pathways; and to identify most cost-effective diagnostic pathways for each type of
abnormality. This information is of vital importance to ensure that the reduction in lung cancer
mortality reported by the NLST is achieved in the community setting.

Public health relevance
The goal of this project is to compare the efficacy of lung screening in community practice with that reported in the National Lung Screening Trial (NLST) with respect to the rate and type of abnormalities suspicious for lung cancer, the rate and type of significant incidental findings that are seen on lung screening and may be clinically important, but that are not related to lung cancer, and the diagnostic testing that is done to evaluate lung and other abnormalities. We will use this information to compare the cost effectiveness of community lung screening with that estimated from the NLST and provide information that can be used to enhance the effectiveness of lung screening in the community.